Summer Training Program in Integrative Methods for Mental and Physical Health

Summary
The goal of this proposal is to continue and expand our state-of-the-art, interdisciplinary training program to
enhance the methodological skills of early-career scientists conducting integrative health research. Mental and
physical health outcomes, and the differences we see across populations, are shaped by social, behavioral,
biological, and environmental factors. However, scientific training on these various factors is often siloed
across disciplines and professions. This lack of integration results in inefficiencies in the growth of scientific
knowledge, limits cross-pollination in interdisciplinary teams, and fosters a piecemeal approach to clinical care
and health services that fails to meet the needs of individuals with complex health conditions, including those
from disadvantaged or minority communities. In 2020, we launched the first NIH-funded training program
focused on building methodological expertise in integrative health, including research on health disparities
across populations. The proposed continuation of the Summer Training Program in Integrative Methods for
Mental and Physical Health will develop the research skills of multidisciplinary cohorts of early-career scientists
on the intersections between social, behavioral, biological, and environmental aspects of health, with attention
to how these intersections contribute to health disparities across populations. This program uses case-based,
applied learning to help trainees explicitly link theoretical models that inform empirical research to the study
designs and analytic tools appropriate for examining mental and physical health outcomes and how they vary
across populations. This is a hybrid training program, consisting of a 3-day residential summer institute which
is paired with 9-months of ongoing virtual mentoring and networking building with senior scholars and peer
alumni, and additional didactic training via webinars. Trainees propose and workshop a research project over
this period, where they directly apply the knowledge and skills they gain through the program. This program is
designed to attract three types of trainees: (i) Behavioral/social scientists who are interested in learning how to
incorporate and analyze biomedical measures; (ii) Clinical/health services researchers interested in assessing
psychosocial and environmental aspects of health; and (iii) Health researchers who want to employ a more
comprehensive approach in their work. The continued success of this program will be evaluated by assessing
trainee skills development, research performance, and sustainable capacity building. Program Leadership has
an established track record of training a wide range of early-career investigators through their leadership of
several Center-based education programs. This renewal will apply the lessons-learned from our decades of
training experience, our strong Institutional Resource Partners, our established national network of Senior
Mentors, and our growing network of Peer Alumni Mentors, in a focused program centered on building the
scientific skills necessary to expand the field of interdisciplinary, integrative health science.

Public health relevance
Narrative The overarching goal of this R25 proposal is to renew and expand the Summer Training Program in Integrative Methods for Mental and Physical Health, a state-of-the-art program designed to enhance the methodological skills of interdisciplinary early-career scientists conducting integrative health research. Biological, psychological, social, and environmental aspects of health are often siloed in research, clinical care, and scientific training, reflecting a piecemeal approach to health that fails to meet the needs of persons with complex conditions. This hybrid training program builds on our successful track-record mentoring junior scientists and leverages extensive institutional resources and a national network of expert consultants to provide focused methodology training in integrative health research.